Speckle x-ray imaging: detecting early changes in lung microstructure

Abstract.
In the United States alone, the number of proton therapy centers has increased to 41 sites, with many more
currently under construction or in planning stage. While the investment for such centers is in the hundreds of
millions of US dollars, research is ongoing to determine whether proton therapy improves treatment outcomes.
A sensitive diagnostic tool for the evaluation of alveoli architecture in this active research area would not only
enable early targeted treatment to slow down progression of radiation-induced lung fibrosis but also
significantly benefit the ongoing preclinical evaluation. The imaging tools currently in use have a poor to
moderate sensitivity that is insufficient for detecting early changes in the lungs and/or are proving impractical
with respect to radiation dose and logistical complexity for longitudinal preclinical studies. To address this critical
need, we introduce an imaging tool for early detection of lung microstructural changes by advancing the
emerging field of x-ray darkfield imaging. In conventional x-ray, image contrast is formed by attenuation based
on the interpretation of x-rays as particles. If sensing x-rays as electromagnetic waves, additional x-ray contrast
mechanisms such as diffraction, phase-shift and small-angle scattering can be accessed. X-ray scattering on
healthy, gas-filled pulmonary alveoli generates a strong darkfield signal, and the signal decreases when
the integrity of the alveoli is affected. Preliminary in-vivo small animal experiments successfully demonstrated
an on average ten-weeks-earlier detection of early onset of radiation-induced lung fibrosis from
conventional photon therapy. A number of methods for acquiring x-ray darkfield images have been investigated
in recent years. However, current solutions require complicated, shock-sensitive and expensive hardware
implementations. A more practical method involves the use of filters consisting of random structures (so-called
diffusers) to generate near-field interference speckle patterns for acquiring darkfield images. Our long-term
goal is translating x-ray dark-field imaging from physics research laboratories into the preclinical imaging arena
to provide the needed tool for longitudinal lung assessment. Our solution includes the design of novel deep-
learning based speckle tracking in combination with a diffuser design based on nanoparticles which is
inexpensive to fabricate compared to gratings. The following specific aims will be pursued: (1) to develop a
software infrastructure for in-vivo small animal x-ray darkfield imaging, (2) to implement an x-ray darkfield
prototype for detection of early pulmonary toxicity from radiotherapy, and (3) to evaluate x-ray darkfield prototype
performance in phantoms and in-vivo longitudinal animal studies. This proposal will advance the field of speckle-
based x-ray dark-field imaging by deepening the basic understanding and by translating it from physics
research laboratories into the preclinical arena. Toward this end, we anticipate that our x-ray dark-field
imaging concept will serve as a low-dose tool for longitudinal in-vivo small animal studies. The proposed
solutions have the potential to drive the translation of x-ray dark-field imaging forward into the clinical routine.

Public health relevance
Public Health Relevance. The number of cancer survivors is steadily increasing; for example, in 2019 an estimated 16.9 million individuals in the United States alone were considered cancer survivors. With this positive upward trend in survivorship, the long-term lung toxicity of radiation therapy gains importance. To address this critical need, we propose a simple, sensitive, and low-dose imaging tool that utilizes a single x-ray projection to detect the early onset of radiation- induced lung fibrosis.